MLK3 in metabolic stress signaling

DESCRIPTION (provided by applicant): Obesity is a world-wide health problem that is associated with metabolic syndrome, including insulin resistance and the development of non-alcoholic fatty liver disease (NAFLD). NAFLD is characterized by hepatic steatosis and varying degrees of inflammation and fibrosis. Increasing evidence suggests that saturated free fatty acids (FFA), by promoting insulin resistance and mediating the progression from simple steatosis to steatohepatitis, are a causative link between obesity and NAFLD. However, the molecular mechanisms responsible for the effects of saturated FFA are incompletely understood. Our long-term goal is to understand the molecular mechanisms by which saturated FFA contribute to the development of NAFLD. Saturated FFA are a major source of metabolic stress that induce activation of the c-Jun NH2-terminal kinase (JNK) pathway, and gene deletion and pharmacological inhibition have established an important role for the JNK signaling pathway in obesity-induced insulin resistance and the pathogenesis of NAFLD. Our preliminary studies identified the MAP3K mixed-lineage kinase 3 (MLK3) as an important mediator of saturated FFA- induced JNK signaling. Thus, we have demonstrated that MLK3 mediates FFA-induced JNK activation, promotes obesity-induced insulin resistance and modulates FFA-induced ER stress response in specific tissues. These data indicate that MLK3 plays a critical role in the development and progression of NAFLD, most likely through metabolic stress signaling. The central hypothesis is that MLK3 contributes to the pathogenesis of NAFLD by mediating saturated FFA-induced JNK activation, thereby inducing inflammatory gene expression, promoting insulin resistance, and modulating ER stress-induced cell death in specific tissues. This hypothesis will be tested by three complementary Aims. In Aim 1 biochemical and molecular biological methods will be used to delineate the pathway(s) required for MLK3 activation by FFA. In Aim 2 biochemical and molecular biological methods will be used to determine the role of MLK3 in the FFA-induced ER stress response. In Aim 3 reciprocal bone marrow transplantation studies will be used to examine the tissue specific role of MLK3 in the development of insulin resistance. Accomplishing the goals of this proposal will increase understanding of the role of MLK3 in the pathogenesis of NAFLD. This information will provide the foundation for the potential development of novel therapeutic strategies for the treatment of this pathology.

Public health relevance
PUBLIC HEALTH RELEVANCE: Non-alcoholic fatty liver disease is the leading cause of liver dysfunction in non-alcoholic, viral hepatitis- negative populations in Europe and the USA. Saturated free fatty acids, by promoting insulin resistance and mediating the progression from simple steatosis to steatohepatitis, are a causative link between obesity and NAFLD. The proposed study will increase understanding of the molecular mechanisms by which saturated FFA contribute to the development of NAFLD. This information may suggest novel therapeutic strategies for the prevention of NAFLD. Project narrative Non-alcoholic fatty liver disease is the leading cause of liver dysfunction in non-alcoholic, viral hepatitis- negative populations in Europe and the USA. Saturated free fatty acids, by promoting insulin resistance and mediating the progression from simple steatosis to steatohepatitis, are a causative link between obesity and NAFLD. The proposed study will increase understanding of the molecular mechanisms by which saturated FFA contribute to the development of NAFLD. This information may suggest novel therapeutic strategies for the prevention of NAFLD. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Obesity is a world-wide health problem that is associated with metabolic syndrome, including insulin resistance and the development of non-alcoholic fatty liver disease (NAFLD). NAFLD is the most common liver disease in western countries (1, 2). The syndrome is characterized by hepatic steatosis and varying degrees of inflammation and fibrosis (3). Increasing evidence suggests that saturated free fatty acids (FFA), by promoting insulin resistance and mediating the progression from simple steatosis to steatohepatitis (4), are a causative link between obesity and NAFLD. Mechanisms responsible for the effects of saturated FFA are incompletely understood, but may include inflammatory cytokines, reactive oxygen species (ROS), and endoplasmic reticulum (ER) stress. ER stress, inflammatory cytokines and ROS are also major sources of metabolic stress that activate the c-Jun NH2-terminal kinase (JNK) pathway. Indeed, gene deletion and pharmacological inhibition have established an important role for the JNK signaling pathway in obesity-induced insulin resistance and the pathogenesis of NAFLD (5-8). MAP kinase kinase kinases (MAP3K) provide selectivity for activation of JNK by upstream stimuli. JNK activated by different MAP3Ks plays a role in a variety of pathologies. Thus, JNK activated by FFA promotes insulin resistance, while JNK activated by other stimuli may function as a tumor and metastasis suppressor (9). Accordingly, drugs that target JNK directly could be beneficial for the treatment of insulin resistance and NAFLD, but this approach might be limited by potential side effects. It is likely that inhibition of the specific MAP3K that mediates FFA signaling may provide greater specificity for therapeutic intervention than inhibition of JNK directly, as only FFA activation of JNK would be affected. Our recent studies identified the MAP3K Mixed-Lineage Kinase 3 (MLK3) as an important mediator of the effects of saturated FFA on JNK signaling and ER stress response. Thus, our results demonstrate that MLK3 is activated in obesity, and mice deficient for MLK3 exhibit impaired JNK activation and increased insulin sensitivity in brown fat and liver as well as reduced hepatic steatosis in a high fat diet model (10). In addition, our preliminary data show that primary hepatocytes deficient for MLK3 exhibit impaired expression of the proapoptotic transcription factor CCAAT/enhancer binding homologous protein (CHOP) in response to saturated FFA-induced ER stress. Together, these data indicate that MLK3 plays a critical role in the pathogenesis of NAFLD, most likely through metabolic stress signaling. The objective of this research proposal is to understand regulation and function of MLK3 in the pathogenesis of NAFLD. Our central hypothesis is that MLK3 contributes to the pathogenesis of NAFLD by mediating saturated FFA-induced JNK activation, thereby inducing inflammatory gene expression, promoting insulin resistance, and initiating ER stress-induced cell death in specific tissues. Our long-term goal is to understand the molecular mechanisms by which saturated FFA contribute to the development of NAFLD. Accomplishing the goals of this proposal will increase understanding of the role of MLK3 in the development of NAFLD. This information will provide a foundation for the potential development of novel therapeutic strategies for treatment of NAFLD. The Specific Aims of this proposal are to: 1. Delineate the pathway required for MLK3 activation by FFA Protein-kinase C (PKC) and CDC42/RAC1 have been implicated in the regulation of MLK3 activity. However, the exact pathway that accounts for FFA-induced activation of MLK3 has not been delineated. Using biochemical and molecular biological methods, we will test the hypothesis that members of the PKC family mediate FFA activation of MLK3 both upstream and downstream of CDC42/RAC1. 2. Determine the role of MLK3 in FFA-induced ER stress ER stress and the unfolded protein response have been associated with the pathogenesis of insulin resistance and the progression of NAFLD. Using biochemical and genetic approaches, we will test the hypothesis that MLK3 and ASK1 cooperate to cause FFA-induced ER stress-mediated JNK activation and that MLK3 promotes ER stress-induced cell death caused by saturated FFA. 3. Examine the tissue specific role of MLK3 in the development of insulin resistance Insulin resistance is thought to be a critical factor in the pathogenesis of NAFLD. However, the cell type in which MLK3 plays a role in this pathology has not been determined. Using reciprocal bone marrow transplantation studies, we will test the hypothesis that MLK3 signaling in specific tissues contributes to the development of insulin resistance.